SWOG Network Group Operations Center of the NCTN

For more than 60 years, the SWOG Member Site Core has accrued at a high level to federally-sponsored cancer
clinical trials. During the formation of the NCTN and within the first successful SWOG application as a Network
Operations Center, we described our preliminary plans for maintaining and enhancing strong member
engagement and brisk trial accrual. We worked hard to achieve the specific aims listed in that document, and
we have dramatically expanded our efforts since, as detailed in this component.